Center for Integrative Biomedical Computing Legacy Transition

Summary
The Center for Integrative Biomedical Computing (CIBC) has an established, twenty year record
as a Biomedical Technology Research Resource (BTRR) whose focus has been technical
research and development in the area of image based modeling and simulation. The resulting
legacy of scientific publications, novel algorithms and computational approaches and especially
a suite of software tools and data sets can continue to support a vibrant research community even
as the twilight requirements of the BTRR program dictate a time limit on NIH P41 funding.
However, while already in heavy use, many of the existing, open source, software tools require
additional hardening, documentation, and user-interface support to reach their full potential. More
important, the software engineering and infrastructure, even though they represent the highest
standards available from an academic center, are not yet robust and flexible enough to sustain
easy maintenance and extension by a community outside the CIBC, a key element to ensuring
the continued health and growth of the impact of these tools beyond the lifetime of the BTRR.
Finally, there are existing collaborators and Driving Biomedical Project (DBP) partners whose
research would suffer with the pending cessation of operations of the BTRR.
We propose a transition plan to achieve long term sustainability of the software and data
resources that the CIBC has produced. The goal of this plan is to complete the conversion of all
the technical products achieved over the lifetime of the Center into well crafted, validated
computer code with all the necessary support for both users and future maintainers of the code
base. We seek to convert our open-source software into something far more valuable: community
supported and sustained software. The conversion will require the assistance of a professional
software house that is familiar with the necessary steps and with the technical domain of our
center, Kitware Inc. Kitware is a company with a long history of assisting biomedical researchers
to develop highly complex software packages and libraries, including VTK, ITK, 3D Slicer, and
ParaView. Members of the CIBC have collaborated with Kitware in the past so there is a proven
relationship on which to pursue the proposed transition plan. This combination of the domain
specific knowledge of the specific tools within the twenty years of the CIBC, along with the ability
of Kitware to support and deploy software and data, will ensure a successful transition and a
lasting legacy from this BTRR.

Public health relevance
Narrative We propose a transition plan to achieve long term sustainability of the software and data resources that the Biomedical Technology Research Resource, “Center for Integrative Biomedical Computing” (CIBC), has produced. The goal of this plan is to complete, with the assistance of the software engineers at Kitware Inc, the conversion of all the technical products achieved over the lifetime of the CIBC into well crafted, validated computer code with all the necessary support for both users and future maintainers of the code base. We will combine domain specific knowledge of the specific tools within the twenty years of the CIBC, along with the ability of Kitware to support and deploy software and data, will ensure a successful transition and a lasting legacy from this BTRR.